Developing a Dre-rox Recombination-Based Genetically Engineered Mouse Model (GEMM) for NUT Carcinoma

Title: Developing a Dre-rox Recombination-Based Genetically Engineered Mouse Model (GEMM) for
NUT Carcinoma.
Project Summary:
NUT-rearranged neoplasm is an emerging group of poorly characterized aggressive cancers caused by fusion
genes, formed by chromosome translocations, involving the testis-specific gene NUTM1, including NUT
Carcinoma (BRD4::NUTM1), undifferentiated small round cell sarcoma (CIC::NUTM1), Porocarcinoma
(YAP::NUTM1) and other poorly understood cancers (caused by fusion genes such as MGA-NUTM1 and MXD4-
NUTM1). Because each NUT-rearranged neoplasm is a rare entity that presents an aggressive disease course,
with an uncertain cell type of origin and is generally resilient to therapies, investigations using preclinical animal
models can provide critical insight into their oncogenic mechanisms and facilitate the development of life-saving
treatments.
By inducing an endogenous chromosome translocation forming the Brd4::Nutm1 using the cre-lox mediated site-
specific recombination (SSR) technology, we have developed the first GEMM recapitulating the syntenic
chromosome translocation event (in contrast to the other reported model that relies on FLEx-mediated ectopic
expression) in NUT Carcinoma (NC) - the most aggressive entity within NUT-rearranged neoplasm. This
innovative GEMM faithfully recapitulated the tissue spectrum, histopathological and molecular features of NCs
and provided a critical preclinical model for this rare but devastating disease. Using this model, we have identified
crucial factors, such as YAP/TAZ, cMYC, and ETV4, that may be required for the initiation and progression of
NC and intriguing putative cancer stem cell populations such as the Sox2-positive cells that may facilitate the
survival and invasion of NC. Conditional genetic manipulations such as conditional knockout (KO), lineage
tracing, and cell ablations are required to functionally dissect the roles of these promising candidate pathways
and cell populations in NC and develop new treatments based on these new understandings.
However, because the NC model is cre-lox-based, it prohibited the application of the inducible cre-lox-based
genetic manipulation technology and the rich resources of floxed alleles and synthetic tools for lineage tracing
and cell ablation. This R03 project proposes to develop and characterize a dre-rox recombination-based
GEMM of NC (Aim 1), and use the model to unravel the critical functions of YAP/TAZ mediated signals
in NC progression (Aim 2).
Overall Impact. Our new model will liberate inducible cre-lox recombination and allow conditional knockout,
lineage tracing, and cell ablation in NC GEMM. The dual recombinase system will deepen our understanding of
the fundamental mechanism of NC oncogenesis and facilitate the effective testing of therapeutic target pathways
for this devastating disease. Furthermore, because chromosome translocation models are modular, by simply
moving one rox site, novel models for other NUT-rearranged neoplasms can be generated and significantly
expand the toolset for understanding emerging and devastating NUT-rearranged neoplasm.

Public health relevance
Project Narrative: NUT-rearranged neoplasm, such as Nut Carcinoma (NC), is an emerging group of aggressive cancers. We have built an innovative cre-lox-based genetically engineered mouse model of NC and will transform it into a dre-rox- based model. The new model will allow the application of dre-cre dual recombinase for mechanism studies and therapeutic target testing and provide a new generalizable strategy for developing preclinical models for NUT carcinoma and other NUT-rearranged neoplasms.